Impacts of Victimization and Caregiving on the Neurodevelopment of Emotion Regulation

1. PROJECT SUMMARY/ABSTRACT
Candidate: I am presently a scientist in the BRAVE Research Center (BRC), within the Department of Psychiatry
at the University of Wisconsin (UW). Career Goals: I seek to identify neural mechanisms though which childhood
adversity can perturb typical development of biobehavioral affective systems in ways that effect enduring
psychiatric risk, as well as moderative ecological factors that may provide a foundation for evidence-based
clinical efforts with vulnerable youth. Career Development: I request support for mentored training to build
knowledge and skills in four areas pertinent to my career goals: (1) theory and analysis of functional brain
networks; (2) caregivers and caregiving as ecological moderators of the linkage between victimization and
psychopathology; (3) data-driven approaches to neurobehavioral analyses and (4) professional development as
an independent investigator. Research Project: The proposed work utilizes longitudinal, multimodal
assessment data from parent-child dyads participating in the Adolescent Brain Cognitive Development study
(N=11,875), and its Social Development sub-study (N=2,500). The primary aim is the evaluation of cross-
sectional and longitudinal changes in functional connectivity networks as mechanisms linking childhood adversity
(victimization) and caregiving practices to impairments in emotion regulation, a biobehavioral domain with
transdiagnostic relevance. First, I will extract robust functional network (static and dynamic) data from quality-
controlled ABCD resting state fMRI scans and evaluate these metrics (and their change across time) as
mediators in a structural equation model linking victimization and emotion regulation. Second, I will consider
main effects of caregiving practices (e.g., positive parenting) on functional network development, as well as
modulative impact on neurofunctional sequelae of victimization. Third, I will develop and evaluate a deep-
learning model predicting impairment in emotion regulation from neural and behavioral inputs, including regional
connectivity, caregiving practices, and exposure to victimization. These results will inform future applications
proposing independent research projects considering neurofunctional mechanisms linking adversity to
psychiatric risk in the context of granular assessment of caregiving practices, caregiver-child relationships, and
dynamics within the broader family system. Such findings may serve as the basis for developing targeted clinical
approaches translating ecological factors shown to moderate the biological and behavioral sequelae of
victimization. Environment: Activities in this proposal will be conducted at UW (BRC, Department of Psychiatry)
under the mentorship of esteemed scientists working in areas of affective and developmental neuroscience,
neural and behavioral sequelae of adversity, quantitative modeling of developmental processes, and machine
learning, led by Drs. Ryan Herringa, Seth Pollak, and Vikas Singh (respectively), each of whom possesses
extensive experience mentoring early career investigators.

Public health relevance
2. PROJECT NARRATIVE Though childhood victimization is an endemic phenomenon, our collective knowledge of how and why such experiences translate into enduring mental health difficulties remains stubbornly underdeveloped, particularly in relation to the underlying neural mechanisms. In children, neural maturation of brain function manifests as a progressive reorganization of networked brain regions exhibiting correlated (or anti-correlated) activation, and alterations in this developmental process may be a biomarker of the protective or potentiating effects of ecolog- ical influences such as victimization or parenting practices. Establishment of functional network dynamics and development as a malleable mechanism linking adversity to impairment in transdiagnostic biobehavioral domains (e.g., difficulties with emotion regulation) can inform development of targeted, evidence-based clinical ap- proaches for vulnerable populations of victimized youth.